Support Activities of the CTEP in the National Cancer Insitute

This contract provides conference planning support services to the Cancer Therapy Evaluation Program (CTEP) located within the Division of Cancer Treatment and Diagnosis in the National Cancer Institute.